Resource Section

PROJECT SUMMARY Resource Core
This application proposes a renewal of the Mouse Mutant Resource and Research Center (MMRRC) at The
Jackson Laboratory. Highly sophisticated genome engineering technologies, a well-characterized genome,
mammalian physiology, and economical husbandry requirements make laboratory mice the mainstay of
biomedical research into disease mechanism and for disease modeling. The NIH has recognized that the
potential impact of genetically engineered mice for biomedical research cannot be fully realized without a
centralized effort to identify, archive, evaluate, characterize, and distribute valuable strains of mice and cell
lines to qualified biomedical researchers. The MMRRC provides this centralized repository function. With over
90 years of mouse genetics and mouse resource experience, The Jackson Laboratory joined the MMRRC in
2009 and remains a key member of the consortium. This proposal requests on-going support for The Jackson
Laboratory as one of the four MMRRC core repositories. As a member of the MMRRC consortium, the Jackson
Laboratory will contribute to the development and improvement of consortium-wide standard operating
procedures. The MMRRC at JAX will follow these mutually agreed upon standard operating procedures in its
efforts to import, archive (through cryopreservation of sperm and/or embryos) and distribute biomedically
important strains of mice and related materials. The MMRRC at JAX will also provide related services on a fee
for service basis and will conduct high-risk, high-return research projects that augment the overall goals of the
consortium.